Pre-clinical development of a small molecule therapeutic for the systemic treatment of idiopathic pulmonary fibrosis

ABSTRACT/PROJECT SUMMARY
Idiopathic pulmonary fibrosis (IPF) is the most common type of pulmonary fibrosis. The disease causes scarring
and stiffness in the lungs resulting in breathing difficulties and eventual death. IPF affects ~3 million people
worldwide, with incidence increasing dramatically with age. Two therapies (pirfenidone and nintedanib) have
been shown to slow IPF progression, however, neither therapy stops or reverses the disease, and both have
significant side effects that limit tolerability in patients. As such, there is a significant unmet clinical need for the
treatment of IPF. In this proposal, we are pharmacologically targeting well-known factors that have been shown
to be essential players in IPF development and progression: 1) gp130 signaling and 2) SRC kinases. De novo
therapeutic 1. Our first therapeutic candidate is a gp130 small molecule modulator, CX-1015. In vitro and in vivo
studies have shown that this molecule targets chronic inflammation and inhibits fibrosis development after injury
through a novel mechanism, which is modulation, not complete inhibition, of gp130 signaling. De novo
therapeutic 2. Furthermore, we have developed a novel class of SRC kinase recruitment inhibitors (SRis) that
prevent cytokine receptor recruitment and subsequent activation of SRC kinases. This technology, termed SRi-
15932, represents a first-in-class approach. The uniqueness of our technology is that unlike other commercially
available SRC kinase inhibitors that bind to the catalytic ATP-binding site within the SRC molecule, SRi-15932,
in contrast, does not inhibit the catalytic activity of SRC as it binds to the molecule’s allosteric site, which mitigates
potential side effects. Just like with CX1015, preliminary studies in vitro and in vivo have demonstrated that
inhibition of SRC by SRi-15932 prevents chronic systemic inflammation and fibrosis in various cell types and
animal models. Importantly, SRi-15932 has shown to inhibit disease progression in a mouse model of IPF. Our
proposed drugs would provide a novel therapeutic advantage over available therapies for IPF. Hypothesis. We
propose that our small molecule compounds will not only inhibit the progression of IPF, but can potentially
decrease mortality rates by reversing, at least in part, fibrotic lung damage. In the UG3 Phase I, we will explore
dose-dependent disease modifying activity and tolerability of both drugs in an aged mouse model of established
IPF and chose the most efficacious candidate. The lead candidate will then be evaluated for its anti-fibrotic
properties in human lung fibroblasts in vitro. In the UH3 Phase II, the lead candidate will be evaluated for its
anti-fibrotic properties in a human ex vivo model of lung slices obtained from late-stage IPF patients. This will be
followed by toxicology studies and optimization of formulation of the compound for oral administration. Expected
Outcomes. Upon successful completion of the study, we expect our technology to not only inhibit IPF
progression, but also reverse the disease, at least in part, which would demonstrate high probability of success
in clinical trials and commercialization.

Public health relevance
PROJECT NARRATIVE Idiopathic pulmonary fibrosis (IPF) is a chronic, progressive lung disease characterized by lung scarring and is considered a disease of aging, with significant treatment costs and socio-economic burden. Currently, there is no cure for IPF, and treatments focus on merely managing symptoms and slowing the progression of the disease. The proposed project has the potential to develop a potent, oral drug candidate for IPF that exerts its therapeutic effects via a novel mechanism and to ultimately advance it along the FDA regulatory pipeline into IND, clinical testing and commercialization.